Label-free cell viability assays using Phase Imaging with Computational Specificity

Project Summary/Abstract
Viable cell concentration is one of the most important key performance indicator during upstream technologies
in mammalian cell culture. Customer Discovery discussions with biopharma execs and R&D specialists revealed
there is an unmet need for on-line/in-line monitoring of cell viability in pharma bioreactors driven by compliance
with real-time product quality assurance as described in Process Analytical Technology (PAT) and Quality by
Design initiatives.
Preliminary work equivalent to Phase I effort has resulted in a cell imaging system including a flow cell setup that
simulates an on-line stirring bioreactor sampling route. Proof-of-concept was also established for detection and
classification of live/dead assays using digital staining via PICS (Phase Imaging with Computational Specificity).
This Small Business Innovation Research project proposes to build a commercial prototype instrument for real
time, quantitative and high-throughput cell viability scoring for on-line/in-line bioreactor monitoring that meets the
metrics of interest for pharma R&D applications. During this effort the standard operation of the QPI+PICS
instrument will be refined and the automated software detection and classification of live/dead assays will be
completed.
At the end of this Direct Phase II project we will deliver a commercial prototype -a “push-of-a-button” viability
scanner with the above capabilities built in.

Public health relevance
Project Narrative Phi Optics proposes to develop an optical instrument for performing real time, quantitative high-throughput viability classification and direct growth monitoring using label-free quantitative imaging combined with novel AI algorithms. The instrument will allow novel bioreactor optimization strategies that could circumvent growth rate limitations and optimize feeding.